EX VIVO GENE THERAPY OF FAMILIAL HYPERCHOLESTEROLEMIA

Scientific aims are 1) to comprehensively evaluate patients with homozygous familial hypercholesterolemia (FH), a genetic disorder associated with very high cholesterol levels and severe premature heart disease; and 2) to treat patients with this disorder using ex vivo liver-directed gene therapy.